Investigating parasitism-induced immune dysregulation and susceptibility to acute rheumatic fever in children

PROJECT SUMMARY
Rheumatic heart disease (RHD) is the leading cause of acquired cardiac morbidity and mortality in young people
worldwide. RHD, a complication of acute rheumatic fever (ARF), develops as a result of strep throat (causative
agent Streptococcus pyogenes). While strep throat is common in pediatric populations, only a small percentage
of infected patients will progress to the severe clinical complications of ARF and RHD. Currently, we cannot
predict which children will progress to the more severe form of disease. The epidemiology and clinical pathology
of RHD is complex and ill-defined. The incidence of RHD in the United States has sharply declined since the
early 1900s, though the incidence of strep throat has remained constant. In high-income countries, even when
strep throat is not appropriately treated, ARF and RHD are extremely rare. Conversely, RHD and strep throat
both remain significant problems in low and middle-income countries (LMIC). Interestingly, the initial decline in
clinicial cases was noted prior to the implementation of regular penicilin use. This decline does, however,
correspond with implementation of more rigorous hygiene practices and the reduced burden of childhood
parasitic infections. Many LMICs, such as Malawi, continue to struggle with a high burden of parasitic infections
and RHD within their population. Parasitic infections cause several systemic health problems such as nutritional
deficiencies, cognitive impairment, and increased susceptibility to secondary infections. Most importantly, certain
parasitic infections skew the immune profile towards Th2 innate and adaptive responses. We believe that this
skewed immune response due to parasitic infection is a driving factor in the development of ARF and RHD in
people with strep throat. This study aims to investigate the role of immune modulation due to co-infection with
gastrointestinal parasites in the progression of strep throat to ARF. We hypothesize that children presenting with
ARF in a highly endemic region of Malawi will more commonly have a co-infection with one or more parasite
when compared to age-matched controls, thereby providing evidence that a parasite-induced altered immune
response leads to increased susceptibility to ARF and severe disease. The overall goal of this study is to
determine if parasite co-infection is significantly higher in ARF and RHD patients and to determine alterations to
the immune profile. Our aims are as follows: (1) Identify the prevalence of parasite infections in children with
acute rheumatic fever who present to health care centers in Malawi compared to age-matched controls, (2)
Examine the extent of immune dysregulation in children with ARF compared to age-matched controls. Our overall
expected outcome from this study is that we will identify a correlation between parasite burden and ARF and
explain the skewed immune profiles that increase risk of severe disease. This study will generate important data
to inform larger prospective studies to identify targets for public health intervention and treatment strategies. We
believe this is an important first step in identifying underlying causes of ARF and RHD.

Public health relevance
PROJECT NARRATIVE Rheumatic heart disease (RHD) is the leading cause of acquired cardiac morbidity and mortality in young people worldwide. Despite strep throat infections being common in resource-rich regions, RHD is rare; however, in low and middle-income regions where parasitic infections are endemic, acute rheumatic fever and RHD are critical public health problems. The overall goal of this proposed study is to determine if alterations in immunity as a result of parasite co-infection drives the development of acute rheumatic fever and RHD after a strep infection.